SCS + CARSS to COSMIIC Adapter Lead

Abstract Summary
SCS+CARSS to COSMIIC Adapter Lead
The goal of this Supplement is to create implantable adapter leads that can connect
between the COSMIIC-style connector and standard spinal cord stimulator (SCS) leads. This
allows users of the COSMIIC System to be able to take advantage of the many different SCS-style
leads available in the medical device industry. In addition, we will create an adapter than can
connect to the CARSS electrode. The CARSS electrode utilizes the standard SCS contacts, and
thus the COSMIIC-CARSS Adapter is effectively a subset of the COSMIIC-SCS Adapter.
The COSMIIC-SCS Adapter will be designed and fabricated in collaboration with Ardiem
Medical (part of the COSMIIC Beekeeper Team). Prototype adapter and leads will be tested in a
saline bath test station to evaluate current leakage from the adapter. Key project tasks include:
1. Design and fabrication of prototype Y-branch connector utilizing COSMIIC System network
cable lead (drawn-filled tube).
2. Concept development of 8-conductor lead compared to existing 4-conductor lead (flexibility)
– select 8-conductor or 2 x 4-conductor lead combination
3. Design and fabricate prototype Tri-Y-branch connector utilizing COSMIIC System network
cable lead with 8 total conductors.
4. Design and fabricate prototype “spade-style” connector for MPS device. Compare insertion-
removal forces with standard single-port connector.
5. Design and fabricate prototype 4 and 8 contact port adapter.
6. Evaluate feasibility of single port adapter design that can accommodate either 4 or 8 contacts
(same adapter can be utilized for SCS leads, DBS leads, and CARSS-style leads).

Public health relevance
Project Narrative SCS+CARSS to COSMIIC Adapter Lead The goal of this supplement is to create an adapter that can connect between standard spinal cord stimulator electrodes and the COSMIIC System.